Mechanistic Investigation of Photoinduced, Copper-Catalyzed Cross-Coupling Reactions

? DESCRIPTION (provided by applicant): Photocatalysis and transition metal-catalyzed cross-couplings are integral in the development of new methods for the synthesis of biologically relevant molecules; however, to date little overlap exists between the two fields. A general photoinduced copper-catalyzed cross-coupling methodology developed by the Peters and Fu labs has demonstrated that irradiation of a copper catalyst in the presence of an aryl or alkyl halide and pronucleophile leads to a variety of carbon-heteroatom bonds, linkages that are invaluable in constructing pharmacophores. Despite the broad scope and utility of these conditions, the mechanisms by which these reactions proceed remain unclear. A mechanistic understanding of these catalytic processes would provide guidance in expanding the scope of the reaction and identifying catalyst deactivation pathways. A comprehensive mechanistic investigation will be undertaken to gain insight into the coupling of thiols and amides to aryl halides using mechanistic model copper complexes. Optical spectroscopy, electron paramagnetic resonance, and fluorimetry will be employed to identify putative intermediates and monitor potential elementary steps. Furthermore, access to laser facilities at the Beckman Institute Laser Resource center will permit observation of transient species and in-depth analysis of the photophysical processes that render copper-nucleophiles potent photoreductants and platforms for bond-formation.

Public health relevance
PUBLIC HEALTH RELEVANCE: Photocatalysis and transition metal-catalyzed cross-coupling are versatile and mild means of constructing carbon-heteroatom bonds, making them powerful tools in the development of pharmaceuticals and biologically active molecules. The proposed research will elucidate the mechanisms by which these bonds are formed in photoinduced, copper-catalyzed cross-coupling reactions. Implementation of advanced spectroscopic and physical inorganic techniques will provide detailed information concerning the intermediates and dynamic processes involved in this catalytic process, and serve as a guide to reaction design and optimization in future studies.